Mechanisms of adhesion and invasion in hyaluronic acid matrices

PROJECT SUMMARY/ABSTRACT
Hyaluronic acid (HA) is the most abundant component of the human brain, where it serves essential structural,
mechanical, and cell-instructive functions. Adhesion between HA and its receptor CD44 critically regulates
development and homeostasis, and dysregulation of HA and/or CD44 causally drives many brain pathologies,
including invasion of the deadly brain tumor glioblastoma (GBM). Despite the clear biological significance of
HA-CD44 adhesion, comparatively little is known about either the biophysical mechanisms through which HA-
CD44 interactions drive cell adhesion, migration, or matrix remodeling or how HA composition (e.g. molecular
weight) influences adhesion and migration. Over the past decade, our team has made seminal contributions to
addressing these questions, including introducing and refining synthetic 3D HA matrices as a culture model for
studying GBM invasion. We also discovered that CD44 transduces HA-based mechanical signals to regulate
cell shape, cytoskeletal assembly, and motility. Most recently, we discovered that GBM cells engage HA using
“microtentacles” (McTNs), CD44-dependenent processes that extend tens of microns from the cell body, are
associated with HA digestion, and mechanically couple to the cytoskeleton through a complex that includes
IQGAP1 and CLIP170. McTNs bear important similarities to structures that have been observed in invasive
GBMs in vivo, and overexpression of McTN components is predictive of with aggressive progression and poor
survival in GBM. In this R01 application, we will leverage these discoveries and biomaterial platforms to
advance the field’s understanding of how HA and CD44 contribute to cell adhesion, migration, and invasion. In
our first aim, we will investigate how McTNs facilitate adhesion, invasion, and matrix remodeling. In our
second aim, we will determine how biophysical features of the HA network in brain tissue contributes to 3D
migration, using GBM as a model system. Our approach is distinguished by tight integration of engineered
biomaterial culture models, mouse models featuring human GBM stem/initiating cells, and analysis of biopsies
obtained from specific anatomic regions of human GBMs. Our multi-institutional team also uniquely combines
expertise in biomaterials, mechanobiology, neurosurgery, and cancer biology. Successful completion of these
studies will yield unprecedented insight into the biophysical basis through which HA and CD44 contribute to
adhesion and invasion, a problem of high fundamental interest that may lead to novel therapeutic targets in
GBM.

Public health relevance
PROJECT NARRATIVE Our proposal investigates molecular mechanisms through which cells adhere to and migrate in/on hyaluronic acid (HA)-based extracellular matrices, with a focus on the membrane receptor CD44. In addition to developing fundamental new insight into HA/CD44-based adhesion, we will apply a variety of model systems to investigate how aberrant HA/CD44 adhesion contributes to the progression of malignant brain tumors.